Ebola Virus and Other Infectious Diseases in DRC and other Countries in Africa (Infrastructure and Capacity)

This funding provides continued support to ongoing initiatives aimed at understanding, treating and ultimately preventing Ebola and other infectious disease initiatives in Africa.